Administrative Core

The Administrative/Educational Core (AEC) ofthe Phase III COBRE is designed to provide oversight to the center, organizational structure to support management of the cores, and support for the solicitation and awarding of pilot grants. This core includes a center director and administrator to provide the interface to the other activities in the center. Additionally, the AEC houses biostatistical/bioinformatics liaison support for linking investigators to thpse resources existing at UK and a training, education, and outreach activity that will cultivate participation of dental faculty and students in clinical and translational sciences research, as well as working through the Dental Public Health outreach program and the UK Health Services Research Center to move the COBRE research accomplishments towards technology transfer and community adoption of new evidence in practice.

Public health relevance
The AEC plays multiple roles in overseeing the progress ofthe COBRE; however, these can be stratified into internal and external effects. Internally, it will oversee the use of key resources and investigators to develop new knowledge to improve oral health. Externally, it will work with community partners in Kentucky to identify opportunities with this new knowledge will be put into action to change oral and systemic health metrics for the population.